RNA binding protein networks and translational control in mammalian oocytes

Throughout the lifespan of a cell, a combination of transcriptional and post-transcriptional regulations control
gene expression, particularly at the time of critical developmental decisions and during the cell cycle. This is
especially true for the development of gametes. Indeed, many pivotal transitions required for the differentiation
of these cells rely more on translational regulation of mRNA than on transcription. To overcome the technical
hurdles inherent in the germ cell experimental model, we have developed novel strategies to investigate how
translation is regulated in mouse oocytes. Monitoring the association of maternal mRNAs with ribosomes
together with single oocyte translation assays has allowed us to view the translational landscape in oocytes
during growth and maturation in ways previously not possible. By monitoring translation at a genome-wide level,
we have identified a global switch in translation that occurs at the time of oocyte reentry into the meiotic cell
cycle. Translation of mRNAs required for oocyte growth ceases, while translation of mRNA coding for cell cycle
components is activated together with translation of components that will be necessary for embryo development.
Using the translation of the critical cell cycle components Cyclin B1 and Cyclin B2 as a paradigm, we have
demonstrated that translation defines some unique properties of the meiotic cell cycle. Here, we propose to
extend these observations by exploring further how differential translation of maternal mRNAs is regulated during
oocyte growth and maturation. The experiments are organized along three specific aims. With the first Specific
Aim, we will investigate the intrinsic features of the 3'UTR of mRNAs translated at high levels during oocyte
growth and quiescence. We will use novel strategies to identify functional elements in the 3' UTR of an mRNA
including those present in the Cyclin B2 mRNA, and to understand how they contribute to translational control in
vitro and in vivo. With the second Specific Aim, we will explore the biochemical properties of protein complexes
that function as repressors of translation, including those involved in repression of CyclinB1 translation. In the
last Specific Aim, we will investigate how repression of translation is triggered at the time of oocyte reentry into
the cell cycle. We will establish links between translational repression and regulation of cell cycle components.
In addition, we will explore the 3' UTR code that defines timely repression of translation and destabilization. The
major outcome of these studies will be a better understanding of the mechanism of repression and activation of
maternal mRNA during gamete development. These studies are significant because they will shed light on how
mRNA translation is intimately involved in regulation of the cell cycle and how translational programs direct
development.

Public health relevance
Narrative The regulation of gene expression is essential for normal cell function, and disruption of this process is often the cause of human diseases. Here, we propose to investigate one aspect of gene expression relatively underdeveloped compared to the mechanisms controlling genes transcription. How mRNA is translated into proteins is emerging as a complex and highly regulated function of the cell critical for most biological processes. We propose to investigate how translation of mRNA into proteins is regulated during the specialized meiotic cell cycle. A better understanding of how this program of translation is executed will provide insight into the mechanisms controlling cell division as well as the processes involved in gamete and embryo development. It will also provide new concepts useful in understanding the causes of chromosome abnormalities.